The Yale WRHR Career Development Center

PROJECT SUMMARY/ABSTRACT
The Yale Women's Reproductive Health Research (WRHR) Career Development Center was established 15
years ago. Its objective is to provide advanced training of Ob/Gyns in basic, translational and/or clinical research
in Women's Reproductive Health, under the guidance of skilled scientific Mentors, in order to produce the next
generation of physician-scientists and leaders in the field. It has been extremely successful. So far, the Yale
Program has mentored 10 Scholars, of which 8 have graduated, and 2 are currently in-training. All our original
graduated Scholars are Division Directors in Ob/Gyn Departments at major US academic institutions, and have
been successful in obtaining NIH research support. Our more recently graduated Scholars have become/are
becoming leaders in their respective fields and also include Division and Fellowship Directors. All hold faculty
positions in Ob/Gyn Departments at major US academic institutions and have obtained research funding. This
proposal is a continuation of this well-established, rigorous, step-wise research-training program. The Program
Director/Principal Investigator (PD/PI) and Research Director (RD) monitor the Scholars’ academic progress
toward independence. We identify prospective scholars from our residents and subspecialty fellows, as well as
by national networking; advertisements in professional journals; letters to Program Directors and Chairs; and
postings at national meetings. Our Advisory Committee chooses Scholars exhibiting exceptional promise and
commitment to a career in Women's Reproductive Health Research. The PD/PI, RD, and Advisory Committee
are directly involved in the training, evaluation and academic development of each Scholar, and monitor their
progress toward research independence. Mentors are experienced in career development and are outstanding
scientists in fields related to Women's Reproductive Health. Core training laboratories in Molecular and Cellular
Biology along with a didactic program are required for all Scholars, including instruction in the responsible
conduct of research. There are two Scholars in the Department at any given time, with each assigned laboratory
space with access to shared teaching and training cores. In order to pursue career development, at least 75%
of the Scholars' time is devoted to research, plus support for up to 5 years to underwrite costs while they obtain
preliminary data for grant applications. During this time, our goal is for Scholars to obtain competitive NIH and
other funding sufficient to suppport an independent academic career. Scholars enter the Department as Assistant
Professors, with appropriate office space and support staff. Clinical duties and responsibilities relate directly to
their research interests. The Yale WRHR program is extremely popular and competitive allowing us to rapidly fill
open positions with outstanding candidates. The overall impact and effectiveness of the program and its quality
are evidenced by the success of all of our scholars. The Yale WRHR Center aims to foster Scholars' development
into independent investigators. Yale seeks to retain, as faculty, Scholars who successfully complete this
individualized training program and who have made significant progress toward independent funding.

Public health relevance
NARRATIVE The Yale Women's Reproductive Health Research (WRHR) Career Development Center provides advanced training of obstetricians and gynecologists in basic, translational, and/or clinical science in order to produce the next generation of highly skilled physician-scientists and leaders to contribute to the improvement of women's reproductive health.